STRESS PROTEIN INDUCTION &PSYCHOSIS

We have discovered that a class of drugs that block the glutamate NMDA (N-methyl-d-aspartate) receptor in the brain, including phenyclidine, ketamine and MK801, damage and kill nuerons in the rat brain. This damage can be detected using molecular markers for stress proteins, including the inducible HSP70 heat shock protein, and the inducible H01, HSP32 hemeoxygenase stress protein. Phencyclidine, ketamine, and MK801 induce HSP70 and H01 in damaged neurons in the cingulate cortex, hippocampus and other regions of the rat brain which has a dose threshold, is dose related, and can be prevented by a variety of drugs including antipsychotics. All of these drugs cause acute psychosis in human patients, and the psychosis can resemble that observed in schizophrenia. The damage produced by these drugs and the neurons involved could be related to those that are affected in psychotic schizophrenic patients. The current project was aimed at determining whether these NMDA receptor antagonists would damage neurons in the monkey brain. Adult monkeys were injected either with ketamine (20mg/kg), MK801 (1mg/kg) or with phencyclidine (20mg/kg). Control monkeys were injected with saline. One day later the monkeys were anesthetized with ketamine and perfused with formaldehyde. Brains were removed and sectioned on a vibratome. Regions of interest included the cingulate cortex, piriform cortex, and hippocampus. Brain sections were then processed for HSP70, H01 and GRP75 proteins using immunocytochemistry. Comparisons of brain sections from saline injected animals and animals injected with ketamine, MK801 and phencyclidine have shown no differences of any type. The HSP70 and H01 proteins are detected in primate brain but the drugs do not appear to induce the stress genes. Our results to date do not support the idea that the drugs tested cause temporary or permanent neuronal injury in the primate brain.